The mechanism of B-catenin-induced Disc Degeneration

Project Summary We have found that β-catenin protein is highly up-regulated in disc tissues derived from patients with disc degeneration and have created a β-catenin conditional activation mouse model which displays severe defects in disc tissue morphology and pain. β-catenin plays a key role in the development of disc degeneration and one of the key signaling mechanisms is to activate Runx2 expression which subsequently regulates Mmp13 expression in Col2-expressing cells in disc tissue. In this study, we will determine the role of Runx2 and CCL2 in β-catenin-induced disc degeneration

Public health relevance
Project Narrative The intervertebral disc (IVD) degeneration is a natural progression of the aging process associated with chronic back pain. β-catenin protein is highly up-regulated in disc tissues derived from patients with disc degeneration and β-catenin conditional activation mouse model displays severe defects in disc tissue morphology and pain. We propose to determine the role of Runx2 and CCL2 in -catenin-induced disc degeneration. The goal of this research is to discover potential targets for the development of effective therapies of human Degenerative Disc Disease (DDD) and associated pain mechanisms..